Breast and Other Cancers in the California Teachers Cohort

DESCRIPTION (provided by applicant): Major shifts in three cancer risk factors over the past decade are changing the profile of women's cancer risks. The California Teachers Study (CTS), a prospective cohort study that has actively followed 133,479 female California public school professionals for incidence of cancer and other outcomes since 1995, is ideally poised to evaluate how the societal transitions of decreasing physical activity, increasing obesity, and increasing aspirin use affect risk of breast and other cancers. The CTS is a unique repository of exposure data over the life course on these important, modifiable cancer risk factors. Our three aims address associations between these shifting exposures and risk for breast cancer overall; breast cancer subtypes defined by hormone receptor status, HER-2 status, histology and stage; and other cancers, with subtypes defined by tumor location or histology. For breast cancer, gene-environment interactions will be assessed by genotyping single nucleotide polymorphisms (SNPs) in genes in key mechanistic pathways (particularly in inflammation, immune function, and insulin resistance pathways), as well as highly significant, replicated SNPs from genome-wide association studies. In Aim 1, we seek to understand better how physical activity reduces breast cancer risk, investigating whether variation in genes involved in fitness or athletic ability interacts with physical activity patterns defined by age and recency, and whether any associations with physical activity are modified by other environmental or genetic risk factors. We also examine how lifelong and changing patterns of body fat and obesity (Aim 2) and aspirin use (Aim 3), over a woman's lifespan influence women's breast, endometrial, ovarian or colon cancer risk overall and by subtype, investigating effect modification, and, for breast cancer, gene-environment interactions. To accomplish these aims, we will continue our current follow-up for cancer and other outcomes, which link to databases that capture 100% of these endpoints among California residents. We will collect and update time-dependent exposure data to broaden our existing information on key exposures from teenage years to old age. We will expand blood collection among breast cancer cases and controls, employing new collection approaches to ensure high participation and forging new scientific collaborations to fully utilize this biospecimen resource. We will continue analyzing key etiologic predictors of cancer using statistical approaches that account for missing data and secular changes in exposures and incorporate high-dimensional genetic data into existing models.

Public health relevance
Public Health Relevance: Successful completion of these aims, following a decade of profound transition in physical activity, obesity, and aspirin use, will permit evaluation of the population impact of these changes on women's cancer incidence, and provide insight into the interplay of genes and exposures for breast cancer. This application focuses on the etiology of major women's cancers and emphasizes common, modifiable, behavioral risk factors in ways that can facilitate future population-wide cancer prevention efforts. PUBLIC HEALTH RELEVANCE: The California Teachers Study spans more than a decade of profound transitions in women's health behaviors, including increasing physical inactivity, obesity, and aspirin use. By examining how these common, modifiable risk factors interact with other environmental and genetic risk factors to influence development of breast and other cancers in women, this study will provide critical new knowledge that can serve as the basis for behavioral public health interventions that benefit women on a population-wide scale. The California Teachers Study spans more than a decade of profound transitions in women's health behaviors, including increasing physical inactivity, obesity, and aspirin use. By examining how these common, modifiable risk factors interact with other environmental and genetic risk factors to influence development of breast and other cancers in women, this study will provide critical new knowledge that can serve as the basis for behavioral public health interventions that benefit women on a population-wide scale. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Dramatic secular changes have occurred during the last decade in the prevalence of several factors associated with breast and other cancers in women. Rates of obesity, physical inactivity, and prophylactic use of low-dose aspirin have consistently increased, and use of hormone therapy (HT) has decreased. This rapidly changing population profile underscores the importance of understanding the roles played in cancer development by obesity phenotype, physical activity, and aspirin use, because each is immediately modifiable, and thus, amenable to community-wide public health intervention. The 133,479-woman California Teachers Study (CTS) cohort has spanned this decade of profound transition and is a unique repository of exposure data over the life course on these important cancer risk factors, including height, weight (at age 18, in 1995-1996, f in 2005-2007), waist and hip circumferences, long-term (from high school to age 54 years or current age) and recent (during the three years before joining the cohort and in 2005-2007) physical activity, and historic use of non-steroidal anti-inflammatory (NSAID) agents, particularly aspirin, (in 1995-1996 and in 2005-2007). The CTS cohort is linked to the California Cancer Registry (CCR), which ensures the identification of all cancers diagnosed among California residents. Record linkage with statewide hospitalization data identifies all discharge diagnoses among participants, including up-to-date information on births, hysterectomies, oophorectomies, hip fractures, etc. The breadth and detail of exposure data and the size and maturity of the CTS cohort allow us to evaluate the population impact of these critical changes in exposure on women's cancer incidence to provide the evidence needed to plan public health action with population-wide impact. Our specific aims make use of information on breast cancer subtypes (defined by histology, hormone receptor status, human epidermal growth factor receptor [HER]-2 status, or stage) and other cancers (defined by histology or tumor location). Our aims also focus on genetic and environmental risk factors (GxE interactions) for breast cancer and its subtypes, including single nucleotide polymorphisms (SNPs) in genes in key mechanistic pathways (hereafter referred to as candidate SNPs), as well as highly significant, replicated SNPs from genome-wide association studies (hereafter referred to as GWAS SNPs). Our specific aims focus on three immediately modifiable exposures, obesity, physical inactivity and aspirin use. Specific Aim 1: Physical Activity. Societal declines in physical activity are seen worldwide, as mechanization and sedentary activities (e.g., television watching and computer use) have replaced physically taxing activities. Higher levels of physical activity reduce risks of breast and colon cancer, but exercise participation and exercise benefits may be influenced by genes associated with fitness, endurance, and athletic ability. The interaction between physical activity and these genes has not yet been studied in relation to breast cancer risk. Further, physical inactivity is likely to assume greater public health importance as an independent risk factor for both breast and colon cancer now that fewer women are using HT. Increasing obesity is also likely to impact risk of these two cancers, and the interaction of obesity with physical activity is complex. We will study SNPs in relation to breast cancer, and we will examine patterns of effect modification by HT and obesity on the association between physical activity and breast and colon cancers. We propose: a. To determine whether common variants in genes associated with endurance, muscle strength, training response, physical fitness or athletic ability are independently associated with long-term physical activity and combine with physical activity to influence risk of breast cancer overall or by subtype. b. To determine whether common variants in genes in inflammation, immune function, or insulin resistance pathways or emerging from GWAS findings interact with long-term or recent physical activity to influence risk of breast cancer overall or by subtype. c. To determine whether HT cessation and increases in obesity modify associations between physical activity and subtypes of breast cancer and colon cancer. Specific Aim 2: Obesity Phenotypes. The escalating proportion of overweight and obese women will have a major influence on population cancer patterns. The impact of obesity may change as a result of declining HT use. Obesity results from interaction between multiple genes and lifestyle factors, including physical activity and diet. Particular combinations of etiologic factors among overweight or obese women produce unique obesity phenotypes that have specific cancer risks. For breast cancer, candidate SNPs in genes in obesity- associated pathways may interact with obesity phenotypes to influence breast cancer risk. We propose: a. To explore how lifetime obesity phenotype (defined by combining data on temporal changes in overall adiposity with adult body fat distribution) is independently associated with common subtypes of breast, endometrial, and colon cancers. b. To evaluate whether these obesity phenotype-cancer associations are modified by other established 1 cancer risk factors such as physical activity, menopausal status, HT and oral contraceptive use, dietary intake, diabetes, and smoking. c. To determine whether common variants in genes in inflammation, immune function, or insulin resistance pathways or emerging from GWAS findings interact with obesity phenotype to influence risk of breast cancer overall or by subtype. Specific Aim 3: Aspirin Use. No current breast cancer chemopreventive drug (e.g., tamoxifen or raloxifene) has promise as a population-wide intervention. Successful chemoprevention programs require an approach that is simple, inexpensive, widely accessible and relatively safe. Aspirin may represent one such option, but because of its use in cardiovascular disease prevention, a clinical trial of aspirin to reduce breast cancer risk is unlikely and observational data become paramount to understanding whether aspirin benefits all women or whether its benefits are limited to subgroups of women or certain breast cancer subtypes. We propose: a. To evaluate whether associations of breast cancer with regular aspirin use (of varying doses and durations) are modified by HT exposure characteristics, other risk factors, or tumor characteristics. b. To explore whether common variants in genes involved in inflammation, immune function, cyclooxygenase (COX)-2 or aromatase action, or emerging from GWAS findings interact with regular aspirin use to influence breast cancer risk overall or by subtype. Specific Aims 1-3 will be accomplished in the context of continued infrastructure activities (described in Progress Report and Study Methods) to maintain cohort contact and follow-up for cancer diagnoses, mortality and hospitalizations. We will also collect additional data to update exposure information on obesity, physical activity, aspirin use and emerging risk factors by sending a questionnaire in Year 2, with telephone follow-up of non-respondents in Years 2-4 to ensure a high level of participation. We will expand our efforts to evaluate genetic associations to 1) increase our statistical power to detect main and GxE interactions, particularly for breast cancer subtypes; 2) generate a case-control sample size that is large enough to detect new main effects that can be rapidly and independently replicated in other studies and consortia; and 3) allow us to mine our existing detailed physical activity, obesity, and aspirin exposure data to uncover GxE interactions that might not emerge with crude measures of environmental exposures. Our increased emphasis on participating in pooling consortia and validation efforts such as the Breast Cancer Association Consortium (BCAC), the NCI Cohort Consortium, the Epidemiology of Endometrial Cancer Consortium (E2C2), and a replication of the breast cancer GWAS among African-American women will facilitate the timely exchange of ideas, results, and data in pursuit of greater knowledge in the rapidly evolving arena of genetic epidemiology. 2